High-throughput discovery and modeling of protein stability and dynamics

Project Summary
Recent breakthroughs in machine learning have stunned the world by making it possible to accurately predict
folded structures for an enormous variety of protein sequences. These breakthroughs signaled the power of
innovative algorithms and large datasets to unlock the hidden information in a protein’s sequence. Still, this only
scratches the surface of what protein sequences can tell us. The goal of this project is to uncover the next layer
of information hidden in protein sequences by measuring global folding stability and folding energy landscapes
for thousands to millions of protein domains. Due to experimental limitations, these properties have historically
been challenging to investigate at scale. Using new experimental methods developed by our lab, this project will
lead to unique, massive datasets quantifying these two properties. These datasets will empower computational
researchers in our own lab and around the world to develop new predictive models that can be applied in drug
and vaccine development as well as in basic research.
Global folding stability describes the physical propensity of a protein sequence to fold or unfold, and stability
influences nearly every other protein property, including function, aggregation propensity, cellular abundance,
immunogenicity, and more. Engineering higher stability proteins is a major goal in drug and vaccine
development, and determining how genetic variants influence stability is a key goal in precision medicine.
Computational tools to predict stability are widely used, but these tools have limited accuracy due to the low
quantity of stability data available for optimizing the models. Here, we will use a new method developed by our
lab to measure stability for three million new sequences (>100-fold more than all available traditional stability
measurements), then use these data to develop a new accurate predictive model for protein stability.
Folding energy landscapes describe the relative energies of all the different conformational states of a protein,
including folded, partially folded, and unfolded states. Even when two proteins have similar structures and similar
global stabilities, they can have very different energy landscapes, leading to different behavior in biological
systems and in therapeutic development. These energy landscapes are challenging to study experimentally and
have never been analyzed on a large scale. Our lab recently broke this barrier by developing a new experimental
approach to measure these energy landscapes for thousands of proteins in parallel. Here, we aim to extend our
method to new, larger protein libraries and improve the level of detail we resolve about each protein’s landscape.
Finally, we will use these improved datasets to develop machine learning models to predict energy landscapes.

Public health relevance
Project Narrative Most proteins fold into complex structures that enable those proteins to carry out their biological functions. We study the stabilities of these structures (the propensities of different proteins to stay folded) and the dynamics of these structures (how they fluctuate and change on very short timescales). By measuring stability and dynamics for millions of proteins in parallel, we aim to develop predictive AI models that can be used in medical research and to develop protein therapeutics.